Use of Noninvasive Biomarkers and Advanced MRI for early detection of NF1-associated MPNSTs

ABSTRACT
Approximately 120,000 Americans with neurofibromatosis type I (NF1) suffer a constellation of
clinical manifestations, including aberrant proliferation of neural tissues leading to malignant
peripheral nerve sheath tumors (MPNSTs). MPNSTs are highly aggressive sarcomas with a
high risk of recurring and spreading, resulting in a 5-year survival rate of less than 25%. Early
diagnosis and intervention offer the best outcomes. However, the lack of convenient and
specific diagnostic tools is a major barrier to optimal therapeutic intervention. Conventional
imaging modalities such as computed tomography (CT scan) and 18F-fluoro-d-glucose positron
emission tomography scans (PET scan) are insufficiently specific. Further, lesion biopsies are
extremely painful and have limited value due to the heterogeneity of these tumors. Therefore,
accurate biomarkers for diagnosis and post-treatment monitoring of MPNSTs are critically
needed. The long-term goal of this proposal is to deploy cfDNA-based biomarkers in patients
with NF1 into routine clinical use to improve early detection of malignant transformation and
monitor responses to therapy. The objective of this proposal is to establish a diagnostic panel
of DNA methylation markers, cfDNA-derived tumor fraction, and aneuploidy profiles that
correlate with and complement imaging-based modalities for a clinically effective tool to
distinguish the presence of MPNSTs from plexiform neurofibromas. Our central hypothesis is
that MPNSTs arising in patients with NF1 have unique DNA methylation and somatic
chromosomal copy number profiles (aneuploidy) that can be detected in the plasma and serve
as clinical biomarkers for early diagnosis or guide therapeutic strategies. We propose 4
Specific Aims: 1) Demonstrate methylation profiles as biomarkers of MPNST in plasma
samples; 2) Establish aneuploidy and tumor fraction as biomarkers of MPNST; 3) Evaluate the
role of advanced MRI in the early detection of MPNST; 4) Determine the feasibility of cfDNA
biomarkers to predict malignant transformation and recurrent disease. Upon conclusion, we
anticipate the development and validation of cfDNA methylation markers, cfDNA-derived tumor
fraction, and aneuploidy profiles that can complement imaging-based modalities and can help
physicians in the early detection of MPNST. Our studies are significant because they will
facilitate early and accurate diagnosis of these aggressive tumors and, consequently,
expedite appropriate treatment, thereby improving patient quality of life, including survival.

Public health relevance
Project Narrative Neurofibromatosis type 1 (NF1) is an inherited genetic condition in which benign tumors develop along the nerve tissues. Challenges for the clinical management of this disease include the surveillance patients must undergo, a relative paucity of treatment options for late-stage disease, and the monitoring for recurrence following surgical treatment. We propose to apply state of the art genomic technologies and novel computational algorithms to profile blood combined with radiology to support noninvasive risk assessment, early detection, and post- treatment monitoring of this population and to improve patient outcomes.